Mitochondria in cardiomyocyte-fibroblast transcellular cross-talk

Abstract:
Heart is a complex organ characterized by homeostatic crosstalk between cardiomyocytes and fibroblasts. This
homeostasis is altered upon cardiac injury, wherein cardiomyocyte-derived factors are known to mediate
fibrobroblast to myofibroblast differentiation as a repair mechanism. Contrary to the classical factors, we found
intact mitochondria to be the conduits of trans-cellular signaling between cardiomyocytes and fibroblasts. Since
phosphoinositide 3-kinase γ knock out (PI3Kγ KO) mice have a pro-fibrotic phenotype with cardiac fibrosis at
baseline with age, proteomics was performed on conditioned media/secretome of isolated adult cardiomyocytes
from PI3Kγ KO and wild type (WT). Secretome from PI3Kγ KO cardiomyocytes was significantly enriched in
mitochondrial proteins, despite no differences in cardiomyocyte apoptosis between PI3Kγ KO and WT.
Interestingly, increased uptake of MitoTracker was observed in the PI3Kγ KO cardiomyocyte secretome
compared to WT. MitoTracker staining was observed only in the mitochondrial enriched buoyant fraction
following sucrose-density gradient fractionation showing intact mitochondria in the cardiomyocyte secretome.
Transmission electron microscopy showed budding mitochondria from cardiomyocytes not only in PI3Kγ KO, but
also in WT. Finding of lower amounts of mitochondria in the WT secretome compared to PI3Kγ KO indicates a)
PI3Kγ negatively regulates mitochondrial release from cardiomyocytes, and b) intact mitochondria is a part of an
yet to be determined cardiomyocyte-fibroblast trans-cellular homeostatic cross-talk whose dysregulation may
underlie cardiac fibrosis. Acute myocardial ischemia (MI) leads to cardiomyocyte injury/death that could release
mitochondria which would be taken up by subjacent fibroblasts leading to accelerated myofibroblast
differentiation and scar formation to maintain structural integrity. Consistently, incubation of C57Bl/6 WT primary
cardiac fibroblasts with sucrose-gradient purified labeled mitochondria from the cardiomyocyte secretome
showed mitochondrial uptake and myofibroblast differentiation. Importantly, only intact mitochondrial fraction of
the cardiomyocyte secretome showed myofibroblast differentiation compared to non-mitochondrial fractions or
broken/fragmented mitochondria. Based on these exciting preliminary data, we hypothesize that intact
mitochondria are trans-cellular signaling conduits between cardiomyocytes and fibroblasts accelerating
myofibroblast differentiation. To test whether this trans-cellular cross-talk occurs between cardiomyocytes and
fibroblasts, we plan to employ a repertoire of ex vivo tools and reagents, and unique genetically engineered
mouse models to address the hypothesis through these studies: Aim 1: To test whether cardiomyocyte-specific
expression of inactive PI3Kγ determines release of intact mitochondria through regulation of SNARE protein
Vti1A, Aim 2: To evaluate whether fibroblast uptake of cardiomyocyte-mitochondria is necessary and sufficient
to mediate myofibroblast differentiation/fibrosis, and Aim 3: To determine whether uptake of cardiomyocyte
mitochondria by cardiac fibroblasts activates TLR4-STAT3 pathway to mediate myofibroblast differentiation.

Public health relevance
Project Narrative: Cardiac injury leads to cell death, wherein fibroblasts are the key cells that mediate repair mechanisms determining the fibrotic outcomes and cardiac function. Fibroblasts in the heart transition to myofibroblasts replacing the dead cardiomyocyte and develop a pro-contractile phenotype supporting heart function. Our studies show that mitochondria released from cardiomyocytes can be taken up cardiac fibroblasts that determines myofibroblast differentiation.